Research Resource for Complex Physiologic Signals

PhysioNet, established in 1999 as the NIH-sponsored Research Resource for Complex Physiologic Signals,
has attained a preeminent status among biomedical data and software resources. Its data archive was the first,
and remains the world's largest, most comprehensive and widely used repository of time-varying physiologic
signals. Its software collection supports exploration and quantitative analyses of its own and other databases
by providing a wide range of well-documented, rigorously tested open-source programs that can be run on any
platform. PhysioNet's team of researchers drive the creation and enrichment of: i) Data collections that provide
comprehensive, multifaceted views of pathophysiology over long time intervals, such as the MIMIC (Medical
Information Mart for Intensive Care) Databases of critical care patients; ii) Analytic methods for quantification of
information encoded in physiologic signals relevant to risk stratification and health status assessment; iii) User
interfaces, reference materials and services that add value and improve access to the resource’s data and
software; and iv) unique annual Challenges focusing on high priority clinical problems, such as early prediction
of sepsis, detection and quantification of sleep apnea syndromes from a single lead electrocardiogram (ECG),
false alarm detection in the intensive care unit (ICU), continuous fetal ECG monitoring, and paroxysmal atrial
fibrillation detection and prediction. PhysioNet is a proven enabler and accelerator of innovative research by
investigators with a diverse range of interests, working on projects made possible by data that are otherwise
inaccessible. The creation and development of PhysioNet were recognized with the 2016 highest honor of the
Association for the Advancement of Medical Instrumentation (AAMI). PhysioNet's world-wide, growing
community of researchers, clinicians, educators, trainees, and medical instrument and software developers
retrieve about 380 GB of data per day and publish a yearly average of nearly 300 new scholarly articles. Over
the next five years we aim to: 1) Enhance PhysioNet’s impact with new data and technology; 2) Develop new
methods to quantify dynamical information in physiologic signals relevant for health status assessment, and for
acute and chronic risk stratification, and 3) Harness the research community through our international
Challenges that address key clinical problems and a new data annotation initiative.

Public health relevance
PhysioNet, the Research Resource for Complex Physiological Signals, maintains the world's largest, most comprehensive and most widely used repository of physiological data and data analysis software, making them freely available to the research community. PhysioNet is a proven enabler and accelerator of innovative biomedical research through its unique role in providing data and other resources that otherwise would be inaccessible.